NETs as therapeutic targets in obstetric APS

PROJECT SUMMARY/ABSTRACT
Pregnant individuals with the autoimmune disease known as antiphospholipid syndrome (APS) have a
markedly increased risk of late-term stillbirth, intrauterine growth restriction, and severe preeclampsia. Despite
some progress as to how we treat obstetric APS in our clinics—including the routine administration of aspirin
and heparins—prospective studies have found that roughly 1 in 8 APS pregnancies will still end with fetal
demise. Thrombosis is actually a rare feature of APS placental histopathology; instead, common abnormalities
include deposition of complement split products, exuberant decidual neutrophil recruitment, and inadequate
tissue remodeling by extravillous trophoblasts. Indeed, our group previously detected neutrophil extracellular
traps (NETs) in the intervillous space of human APS placentae, where they may disrupt normal trophoblast
functions. NETs are spider web-like tangles of chromatin and microbicidal proteins expelled from activated
neutrophils via “NETosis.” We have previously found that antiphospholipid antibody (aPL)-mediated NETosis is
required for thrombosis in models of APS—and have identified some pharmacologic strategies that can help
restore neutrophil homeostasis (including colchicine, adenosine receptor agonists, selectin ligand inhibitors,
and even natural supplements such as ginger). Would such approaches prove valuable if extended to
APS-associated obstetric morbidity? We believe there is an urgent need to answer this question.
Bolstered by new data indicating that NETosis blockade protects APS mice from fetal loss, the hypothesis
shepherding this proposal is that NETosis inhibitors such as colchicine or dipyridamole could find a place in our
clinics as adjuvants therapies. While this study's disruptive hypothesis means it is not without risk, the reward
will hopefully be sufficient preclinical data to support a clinical trial of a drug like colchicine—which is already
known to have a good safety profile in pregnancy based on its routine use in Familial Mediterranean Fever.
Aim 1 will elucidate mechanisms by which NETosis may contribute to aPL-mediated obstetric
morbidity. Successful completion of this Aim will identify (i) the obstetric APS patient-derived aPL most likely
to trigger NETosis, (ii) the role of NETs in amplifying aPL-mediated trophoblast dysfunction, and (iii) whether
blocking NETosis reduces aPL-mediated obstetric morbidity in mice.
Aim 2 will determine the extent to which administering colchicine and/or adenosine receptor agonists
mitigates aPL-mediated obstetric morbidity in mice. Successful completion of this translational Aim is
expected to further elucidate the role of NETs in aPL-mediated obstetric morbidity, while potentially identifying
new therapies that merit urgent evaluation in the clinic.

Public health relevance
PROJECT NARRATIVE Pregnant individuals with antiphospholipid syndrome (APS) have a markedly increased risk of late-term stillbirth, severe preeclampsia, and fetal growth restriction. Despite some progress as to how we care for these patients, 10-12% of APS pregnancies still end with fetal death. This project will determine the extent to which a type of white blood cell called the neutrophil may be a new therapeutic target in obstetric APS, which could complement existing therapies such as low-dose aspirin, heparin, and hydroxychloroquine.